Investigating Racial/Ethnic Disparities in Hypertensive Disorders in Pregnancy in the US

PROJECT ABSTRACT
Compared to their Non-Hispanic White peers, Non-Hispanic Black persons in the US are 79% more likely to
suffer chronic hypertension in pregnancy, 13% more likely to suffer from a hypertensive disorder of pregnancy
(HDP), and 37% more likely to experience eclampsia. They are also 94% more likely to experience severe
maternal morbidity (SMM) and 60% more likely to die from a pregnancy-related cause. Modifiable risk factors
at the individual and population levels, such as socioeconomic status, structural discrimination, and access to
healthcare, have been associated with higher incidence and severity of HDPs, and with the progression of
HDPs to SMM. These risk factors, which have also been independently linked to SMMs and pregnancy-related
mortality in the absence of HDPs, are unequally distributed along racial/ethnic lines in the state, making the
causal pathways more complex. Thus, the extent to which race/ethnicity moderates the associations between
risk factors, HDP, and SMM remains complex, making it difficult for policymakers to develop effective
strategies to combat racial/ethnic disparities in HDPs in the US. Our long-term goal is to develop interventions
that simultaneously reduce the overall burden of HDPs and reduce the racial/ethnic disparities in HDPs. Our
overall objective for this application is to develop and validate a Markov state-transition decision model of the
natural history of HDPs in the US and use that model to evaluate the potential impact of several proposed
policy solutions. Our central hypothesis is that disparities in the population distribution of modifiable risk factors
(e.g., smoking, BMI, SES, discrimination, and access to high-quality healthcare) influence the observed
racial/ethnic disparities in HDP and HDP-related SMMs in the US. Therefore, a decision model that captures
these differences will more reliably predict the future burden of HDPs in response to different policy
interventions. To achieve the project objectives, we will pursue these two specific aims: (1) Develop and
validate a Markov state-transition model of the natural history of HDP and its impact on mothers and children;
(2) Estimate the potential costs and benefits of primary prevention/treatment strategies that address racial
disparities in HDP in the United States. On completion, we expect to have developed a robust decision-support
tool that incorporates multilevel risk factors to predict differences in HDP burden by race/ethnicity, and that can
be used to test the potential effect of proposed interventions. These positive outcomes will enable the
development and implementation of evidence-based solutions to reduce HDP disparities in the US.

Public health relevance
PROJECT NARRATIVE The proposed program is relevant to public health because women from minority racial/ethnic groups suffer disproportionately more from hypertensive disorders of pregnancy (HDP) compared to their non-minority peers. This study will develop a decision-model platform to facilitate comparisons of potential health benefits and costs of HDP prevention and treatment strategies across racial/ethnic groups in the United States.